Vaccine- and infection-derived correlates of protection for cholera

PROJECT SUMMARY
Vibrio cholerae causes 3 million cases of cholera and 100,000 deaths annually. It also causes large and
deadly epidemics of disease in areas affected by climate and conflict associated humanitarian disasters.
Vaccination is a pillar of the World Health Organization’s plan to reduce cholera mortality by 90% in 2030.
However, cholera vaccine shortages in the face of increasing demand have limited or halted numerous
planned vaccination campaigns globally. Although new, low-cost oral cholera vaccines have been developed
to improve supply, there is no agreement on how to introduce these new vaccines or evaluate their
effectiveness. Traditional randomized trials to test new cholera vaccines require hundreds of thousands of
participants, and the availability of other vaccines with proven effectiveness makes such large-scale trails of
new vaccines unethical. Case-control studies to gauge vaccine effectiveness are another option for testing new
vaccines but these are also resource-intensive and are subject to bias.
For these reasons, the lack of ‘correlates of protection’ (or CoPs) against cholera is a major obstacle to
cholera vaccine development. CoPs are measures of immunity which are accepted markers of an effective
immune response to vaccination. While other infectious diseases have well established CoPs, there are no
widely accepted CoPs for cholera.
To overcome this obstacle, we will identify better CoPs for oral cholera vaccines. We will also compare
these to CoPs derived from natural infection with V. cholerae. This proposal builds on our preliminary data
which shows that several novel antibody-markers distinguish between protected and susceptible individuals
after infection with V. cholerae. This evidence supports our premise that vaccination also will produce immune
responses that accurately predict subsequent immunity to cholera. To test this hypothesis, we will follow a
prospective, longitudinal cohort to identify both natural infection- and vaccine-induced CoPs which distinguish
between subsequently protected and susceptible individuals. The study will be performed both in older children
and adults, as well as young children, who are less well protected by current cholera vaccines.
Ultimately, we expect this study to identify new and better performing CoPs for cholera. The results will
improve our understanding of human immunity to cholera, and directly impact human health by accelerating
the development and licensure of new and better performing cholera vaccines.

Public health relevance
PROJECT NARRATIVE The current supply of cholera vaccines is insufficient, and new lower-cost cholera vaccines have been developed to control the disease globally. However, because we lack accurate immunologic tests to gauge cholera vaccine effectiveness (called ‘correlates of protection’) it is unclear how to best evaluate these new vaccines. In this study, we will identify correlates of protection for cholera which are associated with effective immunity, paving the path for the development and licensure of the next generation of cholera vaccines.